Role of myeloid-derived suppressor cells in local and systemic immunosuppression in glioblastoma

PROJECT SUMMARY: Glioblastoma (GBM) is the most common primary malignant brain tumor, with a median
survival of up to 20 months. Males have a 1.6-fold higher incidence of GBM compared to females and worse
disease outcomes. Immunotherapies, which are currently in clinical trials, have had limited success in improving
patient outcomes. An immunosuppressive microenvironment facilitating tumor progression and restricting anti-
tumor immune response likely underlies therapeutic resistance. Although the accumulation of myeloid-derived
suppressor cells (MDSCs) plays a critical role in the establishment of this immunosuppressive milieu, the
mechanisms by which individual MDSC subsets promote tumorigenesis and are regulated remain poorly defined.
We previously demonstrated that monocytic MDSCs (mMDSCs) infiltrated male tumors at higher rates in
preclinical models and patient specimens. In contrast, granulocytic MDSCs (gMDSCs) expand in the peripheral
circulation of female animal models and the gMDSC gene signature is associated with poor prognosis in female
patients. This variation in MDSC subsets also informed sex-specific therapeutic responses to fludarabine and
anti-IL-1β in preclinical models. More recently, we observed that mMDSCs and gMDSCs have a distinct
epigenetic landscape, which is also informed by biological sex. While this highlights the potential role of
epigenetic regulation of MDSC subset activity, there is limited insight into the mechanisms driving distinct MDSC
subset functions. Our preliminary results suggested that the complement pathway could be one such mechanism
as complement component 1q (C1q) was highly expressed by gMDSCs and elevated in females. Based on these
observations, we hypothesize that epigenetic regulation of C1q informs sex-specific behavior of MDSC subsets
and epigenetic reprogramming of MDSCs will improve the efficacy of T cell-activating strategies. Specific Aim
1 will test the hypothesis that the unique epigenetic signatures of MDSC subsets make them susceptible to
different histone modifiers that can be combined with checkpoint modulators. Sub-Aim 1A will examine the
efficacy of histone lysine demethylase inhibitors on MDSC activity in vitro and in vivo, while Sub-Aim 1B will
attempt to achieve durable anti-tumor immune response by combining lead inhibitors with anti-PD-1, anti-CTLA-
4, and anti-OX40. Specific Aim 2 will test the hypothesis that the C1q locus is differentially accessible between
male versus female MDSC subsets. Sub-Aim 2A will use ATAC-seq and CUT & RUN to evaluate the epigenetic
landscape of complement proteins and specific histone mark occupancy based on the differential histone lysine
demethylase expression profile. Sub Aim 2B will use pharmacological inhibitors to test the sex-specific effect of
histone lysine demethylases on complement regulation. These studies lay the foundation for the development of
epigenetic modifiers for GBM immunotherapies by addressing variations in anti-tumor immunity, repurposing
drugs, and defining targetable pathways. These results are broadly applicable to other cancers and can lead to
advanced treatment opportunities and improved patient outcomes.

Public health relevance
PROJECT NARRATIVE Suppression of anti-tumor immune response is a major mechanism facilitating the progression and therapeutic resistance of glioblastoma (GBM), the most malignant primary brain tumor. The objective of this project is to gain mechanistic insight into the cell-intrinsic factors that drive sex-specific accumulation and function of myeloid- derived suppressor cell (MDSC) subtypes in GBM and elucidate epigenetic regulation of the complement system in MDSCs. The successful completion of this proposal will elucidate novel interventions targeting MDSC subset variation by epigenetic reprogramming and account for sex as a biological variable for improved immunotherapy response.